A Multicenter Randomized Controlled Trial of Surveillance versus. Endoscopic Therapy for Barretts Esophagus with Low-grade Dysplasia: The SURVENT Trial

Project Summary/Abstract
Barrett's esophagus (BE), a metaplastic change of the esophageal lining associated with chronic
gastroesophageal reflux disease, is the only known precursor to esophageal adenocarcinoma (EAC). EAC is
one of the most rapidly increasing cancers in the United States, frequently presenting at an advanced stage
and associated with a dismal 5-year survival rate. Endoscopic eradication therapy (EET) is the standard of
care for patients with BE and high-grade dysplasia (HGD) or mucosal EAC. However, a central unresolved
issue is whether BE patients with low-grade dysplasia (LGD) benefit from EET. The diagnosis of LGD is far
more common than HGD and is associated with a lower risk of EAC, so it is unclear whether the costs and
complications of EET are justified in this group of patients or whether they should simply continue with periodic
surveillance endoscopy. The presence of clinical equipoise and the importance of this question indicates that a
trial of endoscopic surveillance versus EET in this patient population is an urgent, unmet gap in our current
knowledge regarding treatment of this common condition. We are uniquely positioned to address this
significant gap in knowledge as we have assembled a multidisciplinary team with the requisite expertise in the
conduct of clinical trials and biomarker research to ensure successful design and high-quality execution of the
SURVENT trial (Surveillance versus Endoscopic Therapy for BE with LGD). This multicenter randomized
controlled trial (n=530) will compare endoscopic surveillance and EET for the management of LGD using
uniform inclusion criteria, design and endpoints. This trial will also include an observational cohort arm for
those who decline randomization but are otherwise eligible (up to 150 subjects). Following our achievements
during the U34 grant period, we propose the following aims for the U01: Specific Aim #1 will compare the two
approaches using the primary endpoint of neoplastic progression rate (progression to HGD or mucosal or
invasive EAC). Specific Aim #2 will compare patient-centered outcomes such as health-related quality of life
between the two treatment groups. Specific Aim #3 will determine the utility of molecular (TissueCypher and
p53 immunohistochemistry) and imaging (wide-area transepithelial sampling – WATS) biomarkers to improve
risk-stratification in BE with LGD patients undergoing surveillance and EET. Biological samples will also be
obtained at pre-specified time points to establish a biorepository for future translational research initiatives. The
relevance of this work to the public health is high. BE is a common condition, affecting 2-3% of adult US
population and LGD is seen in up to 40% of BE patients. This is a precursor for EAC and millions of dollars are
spent yearly on the management of BE and EAC patients. The impact of our innovative study will include
identifying the best patient-centered treatment approach for BE patients with LGD, which will inform the care of
thousands of patients annually.

Public health relevance
Project Narrative – Public Health Relevance Patients with chronic acid reflux disease are often diagnosed with a precancerous condition called Barrett's esophagus with low-grade dysplasia. This is the “first step” which can sometimes lead to esophageal cancer (a lethal cancer that has increased in incidence over the last five decades). Endoscopic treatments are available to destroy low-grade dysplasia, but these treatments are costly and associated with complications. It is unclear whether patients who develop low-grade dysplasia should undergo these endoscopic treatments, or instead undergo periodic endoscopic surveillance procedures, reserving the endoscopic treatments for only those who develop the more serious high-grade dysplasia or cancer. This study will compare the effectiveness of these two approaches, fundamentally changing the way we manage patients with Barrett's esophagus.